Defining the molecular determinants of mesenchymal lineage allocation in lung development and disease

PROJECT ABSTRACT
The lung is an architecturally complex organ, comprised of specialized epithelial cells surrounded by a dense
network of mesenchyme. Recent work from our lab as well as others has shown that spatially discreet
epithelial to mesenchymal niche signaling is required for proper lung development as well as adult tissue
quiescence and regeneration. These studies prompted us to develop an in vivo pathway reporter system to
monitor mesenchymal signaling pathway activity. Using this reporter system, we have deconstructed the
mesenchyme and classified lineages using innovative methods; Single-Cell and Lineage-Seq transcriptome
profiling, three-dimensional spatial orientation, in vivo response to injury and ex vivo niche support capacity.
We have characterized a mesenchymal alveolar niche cell (MANC) as Wnt responsive, expresses platelet-
derived growth factor receptor alpha (PDGFRa), and is critical for alveolar epithelial cell growth and self-
renewal. In contrast, the Axin2+ myofibrogenic progenitor (AMP) cell generates pathologically deleterious
myofibroblasts after injury. These studies provide a platform for defining the cellular and molecular framework
of the lung mesenchymal niches. Moving forward, in Aim 1 of this proposal, I will examine the lineage ontogeny
of Axin2-positive mesenchyme and elucidate the role of PDGFRa-signaling in controlling lineage allocation and
development of the alveolar niche during the postnatal period of alveologenesis. In the independent phase
outlined in Aim 2, I will define mechanisms controlling the pro-regenerative versus myofibrogenic responses in
the mesenchyme after acute lung injury. Based on bioinformatic analyses using multicellular alignment of
ligand and cognate receptor pairs from the alveolar niche, I will define the impact of Notch and Cxcr4 pathways
in provoking the myofibrogenic response from the AMP lineage, in vivo. Importantly, this proposal outlines a
rigorous training plan that will establish the foundation to advance my career in biomedical research.

Public health relevance
PROJECT NARRATIVE The lung is highly complex tissue that is composed of numerous cell-types that coordinately function to facilitate gas-exchange. In chronic diseases that affect lung health, such as chronic obstructive pulmonary disease (COPD), asthma or idiopathic pulmonary fibrosis (IPF), the interstitial stromal components of the lung undergo deleterious remodeling known as myofibrogenesis. This project will uncover the developmental ontogeny of stromal cell subsets and elucidate cell-specific molecular mechanisms of myofibrogenesis.